Unraveling the Mechanisms of Neurodegeneration in TBCK Encephaloneuronopathy

PROJECT SUMMARY
Neurodegenerative disorders remain a public health burden and lack effective treatments. Rare genetic
disorders can cause neurodegeneration in children, which is particularly devastating. Regardless of whether
rare or common, the mechanisms underlying neurodegeneration remain incompletely understood. For
instance, why neurons may be more susceptible to cell death when a genetic mutation is present throughout
the body? Such is the case in TBCK encephalopathy (TBCKE), a rare autosomal recessive disorder that
causes developmental delay and neurodegeneration in children. We previously characterized the neurologic
phenotype of Puerto Rican children with a homozygous null mutation (p.R126X) in TBCK, and later found
mitochondrial respiratory defects and evidence for abnormal mitochondrial quality control (i.e. mitophagy) in
patient-derived fibroblasts. Nevertheless, the (1) physiologic role of TBCK and (2) how TBCK-deficiency leads
to mitochondrial dysfunction and neurodegeneration, remain unclear. Our data support that Tbck protein may
be part of a novel mRNA transport complex (Five-subunit Endosomal Rab5 and RNA/ribosome intermediary-
FERRY). This complex may attach to early endosomes to deliver RNA transcripts, and therefore contribute to
newly synthesized proteins, to cellular compartments distant from the nucleus, such as axons. Deficits in RNA
transport and local protein translation, particularly to distant axonal mitochondria, have been recently proposed
as a novel mechanism underlying a common neurodegenerative disorder (ALS, amyotrophic lateral sclerosis).
Hence, our central hypothesis is that neuronal vulnerability in TBCK-deficiency stems from impaired transport
of mRNA and/or local protein translation disrupting mitochondrial function. We predict this leads to
compartment-specific mitochondrial deficits, with distal axonal mitochondria being more susceptible to TBCK-
deficiency than those in the neuronal soma. In Aim 1 we will test how TBCK-deficiency impacts mitochondrial
function and mitophagy, using human iPSC-derived neurons (iNeu). Then in Aim 2, we will test how TBCK-
deficiency may affect the function of the FERRY complex, by examining effects in the RNA transcriptome in a
compartment-specific fashion (neuronal soma vs axons). We will also directly assay local protein synthesis to
test if TBCK is leading to mitochondrial dysfunction because of impaired protein translation in axonal
compartments. These experiments will address a gap in knowledge regarding the role of neuronal RNA
transport defects in mediating neurodegeneration, how these defects may particularly impact mitochondria and
the role that Tbck protein may play in the novel FERRY complex. Support from this R01 award will be
instrumental in growing my independent research program as a physician-scientist in a superb institutional
environment. It will also contribute to my long-term goal of untangling disease mechanisms of pediatric
neurodegenerative disorders linked to mitochondrial dysfunction; in order to, ultimately, identify novel
therapeutic targets.

Public health relevance
Project Narrative TBCK-encephaloneuronopathy is a recently described genetic disorder that causes intellectual disability, seizures, and weakness in children across the world. Most of the children affected to date are Puerto Rican and suffer progressive neurodegeneration that leads to premature death. Elucidating how the loss of the TBCK protein leads to neurodegeneration- particularly by examining the novel concept that RNA transport defects preferentially impair axonal mitochondria- may provide insight into the mechanisms underlying neurodegeneration regardless of age, and may help develop new therapies for this devastating disease.